Bacterial manipulation of atypical ubiquitin signaling

Project Summary
Post-translational ubiquitin signaling is emerging as a key component of both immune defense as well as
bacterial virulence. Though they lack a canonical ubiquitin system of their own, pathogenic bacteria have evolved
secreted `effector' proteins to manipulate ubiquitin signals, thereby gaining access to host cell processes
including targeted protein degradation, trafficking, and inflammation. The far-reaching importance of ubiquitin
signaling across many cellular processes stems from its ability to form a diverse set of polymeric chains that
signal for distinct outcomes. The complexity of ubiquitin signaling vastly outweighs our understanding of its
regulation and cellular outcomes. While the signaling roles for some types of polyubiquitin are known (e.g.,
protein degradation directed by Lys48-linked polyubiquitin), the functions of many so-called `atypical' subtypes
have remained a mystery despite decades of research. Remarkably, we and others have recently identified a
series of bacterial effector proteins that have evolutionarily converged upon the specific regulation of atypical
polyubiquitin signals linked through Lys6, suggesting this post-translational signal must play a central role within
the host-pathogen interface. In a fascinating paradox, we find that bacterial pathogens like enterohemorrhagic
Escherichia coli (EHEC) have evolved to upregulate Lys6 polyubiquitin, while others such as Legionella
pneumophila have evolved to downregulate it. Based on our preliminary data and clues from outside the context
of infection, we propose that bacteria hijack Lys6 polyubiquitin as an accelerated proteasomal degradation
signal. We propose to test this hypothesis from three perspectives: 1) understanding the molecular basis of Lys6
polyubiquitin specificity, 2) defining the roles of bacterial E3 ligases that form Lys6 polyubiquitin signals during
infection, and 3) identifying the molecular pathways restricted by bacterial deubiquitinases that remove Lys6
signals. Our study benefits from multiple conceptual and technical innovations, including the ability to rewire
bacterial E3 ligases between Lys6 and Lys48 specificity, allowing detailed studies of their effects on protein
degradation and bacterial virulence. In addition, by removing the ability of L. pneumophila to restrict Lys6
polyubiquitination, for the first time we can identify upstream and downstream regulators of Lys6 signals, as part
of what could be a new arm of cell-autonomous immunity. The insights this work will generate for the fields of
bacterial pathogenesis and post-translational signaling are highly significant, and could lead to new opportunities
for anti-virulence therapeutics. Over the next five years we will open a window into ubiquitin signaling at the host-
pathogen interface in order to understand the evolutionary benefits of regulating this poorly studied, atypical Lys6
polyubiquitin signal.

Public health relevance
Project Narrative The signaling molecule ubiquitin controls many aspects of human biology, and thus serves as both a weapon and a weakness in the defense against invading bacterial pathogens. Bacteria have evolved specialized enzymes that thwart or redirect ubiquitin signaling during invasion, and even manipulate atypical forms of ubiquitin signaling for which we lack a solid understanding of function. Using these enzymes as a starting point, we will describe the mechanisms and rationale behind manipulation of atypical ubiquitin signaling during bacterial infection.